GEM Domains and T cell signaling

DESCRIPTION (provided by applicant): Biological membranes are heterogeneous structures composed of membrane domains with discrete physical properties. Glycolipid-enriched membrane (GEM) domains, or lipid rafts, are one type of membrane domain that is crucial for efficient T cell signaling. Studies of GEM domains in T cells are therefore important for understanding the mechanisms underlying development of the T cell repertoire through T cell signaling, such as positive and negative selection, T cell anergy, and clonal expansion. Studies of GEM domains may also provide important insight into immunological diseases related to these events, such as allergy, autoimmunity, and graft rejection. Our research interests are determining the physical and biological properties of GEM domains in T cell signaling, and our recent studies have used fluorescence imaging to measure GEM domains in situ. Our experiments showed GEM domains are constitutively assembled into micron-size membrane patches through association with the actin cytoskeleton. Furthermore, we found that the GEM enriched patches are mobile and diffuse to the site of T cell signaling. Based on our findings, we propose the model that immune synapses form by an actin-dependent assembly of GEM domains at the site of T cell activation, and that GEM domains serve as a vehicle for targeting signaling molecules to the immune synapse and the T cell receptor (TcR). We will address this model with the following aims: 1) Measure the exchange of GEM-associated Lck with remaining cellular pools of protein using fluorescence photo bleaching techniques and determine the role of protein trafficking in T cell activation. For example, GEM-associated Lck is inactive relative to the Lck in the remaining fractions of the cells. This aim will therefore show if active Lck from the non-GEM pool of the cell is targeted to GEM domains and immune synapses for T cell signaling; 2) Measure the dynamics of GEM domains during T cell signaling. This aim will determine when domain clustering occurs relative to the onset of signals from the TcR. We will also determine if domain clustering coincides with mixing of GEM microdomains; 3) Identify the signals that initiate domain clustering by measuring the effects of over expression of dominant negative constructs of CD2 and Fyn; 4) Determine the effect of TcR antagonists on GEM domains and GEM-associated signaling proteins. This aim will show if the altered T cell signaling that occurs with altered peptide ligands is the outcome of inefficient clustering of GEM domains and inhibition of GEM-associated Lck. This research will provide better understanding of an important class of membrane domains, and how their properties relate to human health and disease.